Deep Learning and Subtyping of Post-COVID-19 Lung Progression Phenotypes

PROJECT SUMMARY
Patients who recover from the novel coronavirus disease 2019 (COVID-19) may experience a range of long-
term health consequences. Since the lung is the primary site of viral infection, pulmonary sequelae may present
persistently in COVID-19 survivors. Thus, clinical assessment of COVID-19 survivors in conjunction with chest
X-ray (CXR) and computed tomography (CT) is recommended. CXR is more accessible, whereas CT provides
more detailed information. Our long-term goal is to develop an integrated deep learning model that can assess
lung images to assist with the management and treatment of long-term sequelae of post-COVID-19 subjects.
The primary objective of the proposed research is to advance contrastive self-supervised learning models that
take advantage of the accessibility of CXR scanners and the accuracy of CT images, identify the subtypes in
patients with post-COVID-19, and characterize clinical, imaging and mechanistic biomarkers within subtypes.
Our central hypothesis is that post-COVID-19 subtypes exist and they are characterized by distinct progression
phenotypes. To test this hypothesis and achieve the primary objective, we will perform the following four specific
aims. In Aim 1, we will advance contrastive learning methods to handle large-scale images with low training
costs, and fine-tune the classifier and the encoder network on large-scale CXR images to detect post-COVID-
19 subjects. In Aim 2, we will advance contrastive learning methods that learn from CT images acquired at
different volumes and different times to differentiate post-COVID-19 subjects from other cohorts and identify
subtypes. In Aim 3, we will apply computational fluid and particle dynamics techniques to derive mechanistic
biomarkers to explain the associations between clinical and imaging biomarkers in post-COVID-19 subtypes. In
Aim 4, we will conduct a human subject study that examines post-COVID-19 subjects at 36-48 months after
initial follow-up visits to assess the progression features of their clinical and imaging biomarkers. In summary,
we will advance contrastive self-supervised learning algorithms based on CXR and CT images, respectively, for
accessibility (Aim 1) and accuracy (Aim 2). We will generate in silico data for feature interpretability (Aim 3) and
gather in vivo data for model training and validation (Aim 4). The pre-trained model from Aim 2 will be fine-tuned
via transfer learning to input CXR images that are classified as post-COVID-19 by the model from Aim 1. An
integrated deep learning model based on the two models from Aim 1 and 2 will take CXR images as inputs to
provide CT-based detailed phenotypic information together with mechanistically and clinically meaningful
interpretation. If successful, our study will not only advance contrastive learning algorithms, but also elucidate
the pulmonary sequelae of post-COVID-19 patients in subtypes and associated clinical, imaging and mechanistic
biomarkers. The ability to identify progression subtypes and associated phenotypic biomarkers will have a
positive impact on the management and treatment of patients with post-COVID-19.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This study seeks to understand the long-term consequences to lung function in patients who recover from the novel coronavirus disease 2019 (COVID-19). The proposed deep learning algorithms will utilize chest X-ray and computed tomography images to identify post-COVID-19 progression subtypes and establish their associations with distinct clinical, imaging and mechanistic biomarkers. The knowledge gained from this study will improve the management and treatment of post-COVID-19 patients.